CK20-004, Chicago Prevention and Intervention Epicenter III (CPIE-III)

Core Project Summary
The Chicago Prevention and Intervention Epicenter will focus on objectives promoted by CDC. Through our
core projects we will make epidemiologic and basic science discoveries and technological innovations
translatable into strategies to prevent spread of antimicrobial-resistant organisms within facilities and regionally
across the web of interconnected facilities. To control endemic antimicrobial-resistant pathogens, and to
mitigate emerging, novel mechanisms of resistance, a bundle of interventions is needed and applied across
the spectrum of healthcare facilities. We propose an ambitious portfolio of projects in hospitals, long-term acute
care hospitals (LTACHs), and skilled nursing facilities. Our projects span the infection control domains of
interest to CDC, annotated by the following six core projects (abridged for this summary):
Project 1: Predictive modeling to identify patients at high-risk for MDROs to inform Illinois' XDRO registry.
Population, hospital and LTACH patients. Domain, regional control including long-term care facilities.
Project 2: Regional active MDRO surveillance with genomic analysis. Population, hospitals, LTACHs and
nursing homes. Domain, containment of novel resistance.
Project 3: Geospatial, ecologic, and clinical risk factors for community-associated ESBL-producers.
Population, emergency department and ambulatory patients of two large, urban health systems. Domain,
community-associated antimicrobial-resistant infections.
Project 4: Genomic epidemiology of MDRO transmission in ICUs. Population, hospital ICU patients. Domain,
applying innovative research methodology to evaluate MDRO transmission.
Project 5: Adverse health outcomes associated with microbiota disruption. Population, medical ICU patients.
Domains, effects of antibiotic use and diagnostics—evaluating measures of the microbiome.
Project 6: Generate and export reports on antimicrobial use metrics from a national common data model.
Population, hospital patients. Domain, Antimicrobial stewardship

Public health relevance
Core Project Narrative/ Relevance We designed projects to protect people from catching hard-to-treat germs in all types of healthcare facilities: nursing homes, long-term ventilator facilities, and hospitals. Diverse interventions are needed in all settings, so we will evaluate how a patient’s own microbes can protect them or may make them vulnerable, learn how bugs spread between people using advanced genetic analyses, facilitate data exchange among facilities, and develop measures of antibiotic use across facilities.